Uncovering the Internal Representation of Actions in Posterior Parietal Cortex

PROJECT SUMMARY
Neurological injuries and diseases negatively affect quality of life for millions of people in the US. In particular,
damage to the posterior parietal cortex (PPC) causes various visual and oculomotor pathologies, including
optic ataxia, oculomotor apraxia, and simultagnosia. Nonhuman primate and human studies have elucidated
how PPC integrates visual and motor information to plan and execute movement decisions. However, much
still remains unknown about how and where PPC represents future decisions and actions. In this
proposal, we will use two complementary techniques, functional ultrasound neuroimaging (fUS) and
electrophysiology, to explore how PPC represents decision and motor variables. These variables include
movement effector, target location, and action desirability. To date, neural recording techniques have sacrificed
spatial and temporal resolution for field of view or vice-versa. Now, fUS is available as an innovative
neuroimaging technique that measures cerebral hemodynamics with exceptional spatiotemporal resolution
(<100 µm; ~100 ms) and a large field of view (several cm) – specifications ideally suited to recording detailed
activity of entire cortical regions in parallel. In addition, we will use electrophysiology, the gold standard for
neuronal recordings, to verify fUS findings at the single-neuron level. In Specific Aim 1, we will investigate the
anatomical organization of movement location in PPC by recording fUS data as rhesus macaques complete
eye and hand movements to visual targets. This will provide a detailed cortical map of response fields in PPC
according to effector and movement location. In Specific Aim 2, we will identify how and where decision
variables (effort and reward) are encoded in PPC. Like Specific Aim 1, we will record fUS data while animals
perform eye and hand movements, but we will also vary reward and effort by independently changing the liquid
reward amount and required accuracy (i.e. effort) for each movement. In Specific Aim 3, we will investigate
the link between cerebral hemodynamics and the underlying neural activity through simultaneous fUS and
broad-band electrophysiology (single-unit, multi-unit, and LFP). We will use these data to 1) validate our fUS
findings and 2) explore interesting patches of activity at the single neuron level. If successful, this contribution
will further validate fUS as a robust and accessible neuroimaging technique for future research and clinical
applications where electrophysiology is difficult to attain and/or scale. Together, these Specific Aims will
elucidate where motor and decision variables are encoded in PPC from the micro-scale (electrophysiology) to
the meso-scale (fUS). By understanding the neuronal circuits influencing visual-motor decisions, we can better
understand visual-motor disorders, e.g. optic ataxia and oculomotor apraxia. This project will be conducted
through the UCLA-Caltech MSTP under the mentorship of Drs. Andersen and Shapiro. The described research
will form the basis of my PhD thesis and instill the skills for me to become an accomplished physician scientist.

Public health relevance
PROJECT NARRATIVE Neurological injuries and diseases negatively affect quality of life for millions of people in the US, such as the various visual and oculomotor pathologies (e.g. optic ataxia and oculomotor apraxia) caused by damage to the posterior parietal cortex (PPC). Despite extensive research, much remains unknown about how PPC encodes motor decisions, in part due to technical limitations of existing neural recording technologies. This project aims to increases our understanding of the neuronal circuits involved in these visual-motor pathologies by using a novel neuroimaging technique (functional ultrasound neuroimaging) and conventional electrophysiology to investigate how and where motor and decision variables are represented from the single neuron level to detailed maps of neural populations across the entire PPC.